Targeting Hypoxia-Inducible Factors (HIFs) for Heart and Lung Disease

PROJECT SUMMARY
The current application for R35 funding is focused on targeting hypoxia-inducible factors (HIFs) for
heart and lung disease. HIFs were discovered as transcription factors that are stabilized during hypoxia and
promote adaptive responses. However, during inflammation or ischemia and reperfusion, changes in metabolic
supply and demand result in inflammatory hypoxia and similarly promote the stabilization of HIFs. Studies from
our laboratory and other investigators indicate that HIFs can dampen excessive tissue inflammation during
inflammatory hypoxia, particularly during myocardial ischemia and reperfusion injury or during acute
respiratory distress syndrome (ARDS). The stabilization of HIFs is controlled by prolyl hydroxylase domain
enzymes (PHDs). Different isoforms of HIFs and PHDs exist, and ongoing efforts are focused on deciphering
isoform-selective and tissue-specific roles for HIFs and PHDs during inflammatory conditions. Moreover,
identifying specific transcriptional target genes and strategies for therapeutic targeting of HIFs are areas of
intense research. Therefore, our NHLBI-funded research has been focused on studying hypoxia-signaling
during inflammatory conditions, including myocardial injury and ARDS. To make progress on this front, we are
requesting R35 funding in support of our “Hypoxia-Inflammation Program” at UTHealth Houston. For this
program, we have incorporated three complementary projects. All three projects are extensions of ongoing
research funded by 3 individual NHLBI R01 grants with Dr. Eltzschig as PI or contact PI (R01HL154720,
R01HL169519, and R01HL165748). Project 1 focuses on the upstream regulation of HIFs by PHDs during
ARDS. Our findings identify a novel feed-forward signaling loop under the control of alveolar-epithelial PHD1.
Project 2 explores the functional roles of HIF-driven microRNAs during ARDS. We identified alveolar miR-147
as a novel HIF-target gene that dampens alveolar inflammation. Project 3 identifies a novel function of HIFs in
mediating circadian variations of myocardial injury. We observed that the core circadian rhythm molecule
BMAL1 forms a transcriptionally active heterodimer with HIF2A that modulates circadian-dependent cardiac
injury. Substantiating this finding, we determined the cryo-EM structure of the BMAL1/HIF2F/DNA complex,
revealing a previously unknown capacity for structural rearrangement within BMAL1. All three project themes
are closely aligned and, as a whole, will provide a comprehensive understanding of molecular pathways that
dampen inflammatory hypoxia, promote cellular resistance to ischemia, and define highly translational
therapeutic targets controlled by HIFs. The projects are further linked by their shared use of technological
resources, our hypoxia-signaling mouse core, and the human hypoxia-signaling biobank. The 7-year
funding period of the R35 mechanism will allow the development of the critical clinical and basic science
infrastructure. The result is a Program in which the whole is greater than the sum of its parts.

Public health relevance
PROJECT NARRATIVE This application for R35 funding is focused on targeting hypoxia-inducible factors (HIFs) for treating heart and lung disease. Studies from our laboratory indicate that HIFs can dampen excessive tissue inflammation and organ injury, particularly during myocardial ischemia and reperfusion injury or acute respiratory distress syndrome (ARDS). We propose 3 Projects that will provide a comprehensive understanding of molecular pathways that dampen inflammatory hypoxia, promote cellular resistance to ischemia, and define therapeutic targets controlled by HIFs during myocardial injury, or ARDS.